Mapping the Glucuronidome

Project Summary
Mapping the Glucuronidome. One of the most important mammalian detoxification (inactivation) methods is the
chemical addition of glucuronic acid to biologically active compounds, glucuronidation. The rate of
glucuronidation is altered by dietary compounds and the successful elimination of glucuronidated chemicals is
inhibited by microbial removal of the glucuronic acid moiety, regenerating the active, and often toxic, compound.
Changes in the pool of glucuronides have important implications for the prevention, diagnosis, and treatment of
chronic diseases. Recent research efforts have focused on the role of microbiome manipulation on drug
metabolism, specifically the inhibition of microbial β-glucuronidase enzymes for reducing adverse drug reactions
to NSAIDs and chemotherapies and improving pharmaceutical treatment efficacy. Comprehensive research of
the physiologic implications of host-metabolite-microbe interactions is possible due to recent advances in mass
spectrometry methods for identifying and quantifying metabolites in complex mixtures (blood, urine, and feces)
and high-throughput -omics techniques for functional analysis of the microbiome. This proposed research aims
to develop an integrative multi-omics pipeline incorporating novel metabolomic methods, metagenomic
sequencing, and molecular biology techniques to define the physiologic effects of host-glucuronide-microbiome
interactions. The training will provide for a collaborative effort between xenobiotic metabolism, mass
spectrometry, and microbiome experts to experimentally disrupt glucuronidation, map glucuronide exchange
dynamics, and quantify resultant host metabolic signaling. The research will provide for the development of a
much needed, first-of-its-kind, comprehensive, and publicly available database of glucuronidation, facilitating the
incorporation of powerful metabolomics methods to research advancing the understanding of xenobiotic
metabolism. The proposed research will inform the current understanding of host-microbiome interaction effects
on xenobiotic metabolism and host health, with important implications for the development of individualized
medicine and microbe-targeted therapies.

Public health relevance
Project Narrative Diet and the microbiome are important risk factors for the development of chronic diseases - cancers, inflammatory bowel diseases, obesity, and type 2 diabetes - and influential modulators of glucuronidation, an essential detoxification pathway. Metabolomics and metagenomics are top-down techniques, which facilitate the identification and quantification of metabolites in complex mixtures (blood, urine, and stool) and the distribution and frequency of microbial genes, respectively. The proposed research aims to integrate high-throughput -omics techniques and traditional molecular assays to define the glucuronidome under normal and disrupted conditions and identify the physiologic effects of shifting glucuronide pools on host inflammation, metabolism, and disease development.